Function of Fixational Instability During Natural Viewing

PROJECT SUMMARY Human eyes are never at rest. Gaze redirections normally occur 2-3 times/second, separating periods of small, incessant eye movements. At ﬁrst glance, the function of eye movements seems obvious: they are necessary to bring and maintain the object of interest within the foveola, the highest acuity region of the retina. However, an overwhelming body of evidence, in part coming from our NIH-funded research, indicates that this view is simplistic and that, by reformatting a spatial scene into a spatiotemporal stimulus on the retina, eye movements serve fundamental visual functions beyond just orienting the foveola. Here we test several new hypotheses concerning less-obvious but equally critical roles for three main kinds of eye movements: saccades, pursuit, and ﬁxational drift (the eye jitter that continually occurs during ﬁxation). The research strategy consists of evaluating the effect of eye movements on the retinal input and the resulting consequences for neural coding, perception, and control. The experiments rely on state-of-the-art high-resolution measurements of human eye movements and gaze-contingent control of retinal stimulation. All experiments are supported by mathematical modeling of visual input signals and neural modeling of their encoding consequences. Aim 1 focuses on the physiological alternation between saccades and ﬁxational drift. Stereotyped, saccade-induced transients are followed by stereotyped, but distinct, periods of Brownian-like jitter of the retinal image. Our preliminary analyses show that this alternation repackages the energy of natural scenes into different spatiotemporal formats, cyclically varying ampliﬁcation and spectral distribution within the temporal sensitivity bandwidth of retinal neurons. The predicted outcomes are oculomotor-driven dynamics of visual sensitivity, discrimination, and form perception during natural post- saccadic ﬁxation, which we will quantify and test. Aim 2 focuses on the saccades themselves. We predict that, as a consequence of a saccade, the spectral density of the visual input effective in driving retinal neurons at ﬁxation onset is equalized up to a cut-off spatial frequency that depends on the saccade amplitude. This effect further constrains visual dynamics and implies that visual coding during early ﬁxation depends on the amplitude of the preceding saccade. It also suggests that the visual system can exploit this tuning according to the task. We will test these predictions by isolating the contributions of saccade transients in a variety of low- and high-level visual tasks. Aim 3 further generalizes these ideas. Building on our modeling work, it examines whether ﬁxational drift can also be adjusted to tune visual sensitivity to the task demands, and whether the alternation between pursuit movements and “catch-up” saccades during visual tracking plays a role similar to that of saccade/drift cycle for static targets. All our hypotheses are supported by preliminary data. They are, to our knowledge, entirely novel, and conﬁrmation of any of them will have broad implications for understanding the design principles of the visual system, possible oculomotor contributions to neuro-ophthalmologic disorders, and the development of rehabilitative strategies and prostheses.

Public health relevance
PROJECT NARRATIVE Eye movements incessantly occur in healthy humans and directly affect the spatiotemporal patterns of light in- cident on the retina. By investigating the functions of eye movements, this project will advance understanding of normal human vision as an integrated sensorimotor process and may lay the groundwork for new treatment approaches for visual impairments, including, but not limited to, those associated with abnormal eye movements.